Mechanisms responsible for tooth morphogenesis in vertebrates

Abstract
Misshapen teeth are highly common in humans. In most instances, they are due to genetic mutations in genes
controlling the morphogenesis of teeth. This is the case for the Runx2 gene, which once mutated leads to
cleidocranial dysplasia (CCD) an autosomal dominant genetic syndrome presenting with peg-like teeth in
humans. While many factors have been identified in the process of tooth morphogenesis, currently, little is known
about how cell signaling participates in establishing organ shape during odontogenesis. Our previous work has
identified the signaling molecule retinoic acid (RA) to be one of the main actors of tooth induction in fish and
recent data suggest that RA also plays a role during tooth morphogenesis. Fish and zebrafish, in particular, are
good models to study genetics, cell and molecular biology, and organogenesis of the tooth in vertebrates. The
objective of the proposed studies is to understand the roles played by retinoic acid during tooth morphogenesis
in different fish species, to develop a fish model of CCD, to clarify the role played by Runx2 during tooth
morphogenesis, and to understand its link with RA signaling. Finally, this project proposes to identify novel genes
implicated in tooth morphogenesis and to study their function by gene knock-outs in zebrafish.
By exposing fish embryos and larvae to exogenous RA and RA inhibitor during tooth morphogenesis we will be
able to understand the mechanism of action of RA signaling during tooth morphogenesis in fish. Our preliminary
data identified that the levels of RA in different cells of the tooth germ are controlled by the timing and level of
expression of the RA degrading enzyme cyp26b1 in a subset of cells of the developing tooth germ. Modifying
the onset of cyp26b1 expression in the tooth germ will, therefore, change the level of RA available in the tooth
germ ultimately modifying the shape of the tooth. We will study the cis-regulatory changes responsible for
evolutionary changes in the timing of cyp26b1 expression during tooth morphogenesis between two closely
related fish species, the zebrafish and the mountain minnow, that bear dramatically different shape of teeth in
adults and during embryonic development. We have in hands the zebrafish runx2b (the zebrafish ortholog of the
human Runx2 gene that is expressed in the tooth germ) loss-of-function mutant. This mutant will be used to
perform a phenotypic analysis of tooth morphogenesis and to understand the relationship between RA signaling
and Runx2 expression during tooth morphogenesis. To identify novels genes playing a role during tooth
morphogenesis, we will select by cell sorting, tooth germ cells exposed to exogenous RA signaling and compare
their transcriptome to control developing tooth cells at the same developmental stage. The resulting genes
differentially expressed will be subjected to phenotypic analysis by gene knock-out using the CRISPR/cas9
technology. This work will reveal more about how RA and genes it regulates, including Runx2, controls tooth
morphogenesis in development, diseases (cleidocranial dysplasia) and evolution.

Public health relevance
Narrative Misshapen teeth are highly common in humans and most cases are due to a genetic mutation like for the Runx2 gene which, when mutated, causes cleidocranial dysplasia (CCD). Retinoic acid is a signaling molecule that plays a crucial role during tooth induction and that we suspect play a major role during tooth morphogenesis. This proposal will develop new fish models to study the role of retinoid acid and the Runx2 gene during tooth formation, clarifying the mechanisms which cause misshapen teeth in CCD and will identify novel genes implicated in the development and evolution of tooth morphogenesis.